A new strategy for vision restoration based on melanopsin transduction mechanisms

PROJECT SUMMARY
A pressing challenge in the treatment of retinal diseases is to restore vision in the retina with irreversible
photoreceptor degeneration. In theory, even in the absence of rods and cones, such diseased retina should still
be able to sense light through intrinsically photosensitive retinal ganglion cells (ipRGCs) using a photopigment
named melanopsin. However, the kinetics of melanopsin-mediated light response is slow, thus giving only very
poor temporal resolution and therefore largely limiting its ability to provide image-forming information. For the
same reason, a vision restoration approach previously proposed – which made use of virally expressed
melanopsin to endow light sensitivity to conventional retinal ganglion cells (RGCs) – is also limited by the slow
response kinetics of melanopsin. Our recent study has firmly established that melanopsin-mediated
phototransduction is rate-limited by its downstream components and that it can be accelerated by virally
expressed ion channels with faster kinetics. We propose to develop a novel vision restoration strategy by
accelerating melanopsin signaling via manipulating downstream transduction components in photoreceptor
degenerated mouse models. We have two major aims. In Aim 1, we shall focus on enhancing the light response
of endogenous melanopsin in M4- and M5-subtypes of ipRGCs because they have been shown to project to
image-forming brain centers, allowing them to contribute to the image-forming vision. We have discovered that
M4-cells respond to melanopsin photoactivation by elevating intracellular levels of cyclic nucleotides (cNMP) and
subsequent opening of cNMP-sensitive HCN channels. Our new preliminary data suggest that M5 cells also use
the HCN pathway. We have further shown that the response of the HCN-dependent signaling pathway can be
sped up by introducing a member of the cyclic nucleotide-gated channel family, CNGA2, resulting in faster
response kinetics and larger amplitudes, proving the concept of our strategy. In Aim 2, we shall restore light
response in conventional retinal ganglion cells using virally expressed melanopsin together with faster signaling
molecules. Our multielectrode array results show that simultaneously expressing melanopsin and CNGA2 in
cRGCs provides higher light sensitivities and faster rising phases than expressing melanopsin alone. Using
water-based vision-guided maze tests, we have further found that exogenous melanopsin and CNGA2 not only
restore light sensitivity but also confer pattern vision in photoreceptor-degenerated animals. Together, these
exciting preliminary observations raise the prospect of using CNG channels and/or modifications to other
phototransduction components of melanopsin as a therapeutic modality to restore vision following photoreceptor
degeneration. Innovation. All optogenetic approaches proposed thus far focus on finding a better light-sensing
protein with higher expression, better light sensitivity, and faster response kinetics. We are the first to exploit
downstream components and novel signaling molecules of melanopsin for vision restoration purposes. This
represents a conceptual innovation and an out-of-the-box strategy for vision restoration.

Public health relevance
Project Narrative A pressing challenge in the treatment of retinal diseases is to restore vision in retina with irreversible photoreceptor degeneration. This project aims at developing a novel gene therapy strategy for vision restoration – using virally expressed phototransduction components in retinal ganglion cells to enhance the light sensitivity and response kinetics of melanopsin. The objectives of this project will have a significant impact on treating blindness and vision loss by providing a knowledge base for future improvement of vision restoration therapy.